MOLECULAR BASIS OF DIFFERENTIATION AND DEVELOPMENT

DESCRIPTION (provided by applicant): The Training Program encompasses pre- and postdoctoral training for individuals interested in the fundamental mechanisms of development, growth and differentiation. Program faculty members are drawn from the Department of Biochemistry and Molecular Biology (8) and Department of Molecular Genetics (3) at the University of Texas M. D. Anderson Cancer Center and the Department of Biochemistry and Molecular Biology (1) at the University of Texas Medical School in Houston. The Program benefits from its location within the multi-institutional Texas Medical Center, a progressive and integrated graduate school, and a strong commitment from M.D. Anderson in educating future biomedical scientists. Program faculty members focus their research on a variety of problems in development, growth and differentiation and are committed to rigorous training of graduate students and postdoctoral fellows. Predoctoral trainees are required to enroll in a broad-ranging curriculum that includes coursework in ethics, biochemistry, genetics, eukaryotic molecular biology, developmental biology and a quantitative requirement. First year students rotate through the laboratories of three different faculty members. Pre- and postdoctoral trainees participate in a variety of Program activities designed to foster interactions and collaborations. These include an annual Fall orientation, student rotations talks Blaffer seminar series, research and journal clubs, and most notably, an annual Program retreat, where trainees and faculty members meet off site to present and discuss their current research results. Predoctoral trainees are selected from a large pool of well-qualified students admitted to the Graduate School of Biomedical Sciences. Postdoctoral trainees are selected from a pool of applicants who have applied or are currently in the laboratory of Program faculty members. The selection of trainees is highly competitive and is based on previous academic and research performance. Past trainees have successfully published in high impact journals and many past trainees now hold postdoctoral and faculty positions at major academic institutions.